Inhibitory Cell Types and Circuits in the Lateral Hypothalamus

PROJECT SUMMARY/ABSTRACT
The goal of this proposal is to define the cellular diversity, connectivity and function of inhibitory neurons in the
lateral hypothalamic area (LHA). The LHA is a linchpin in the orchestration of fundamental aspects of behavior
owing to its unique position at the intersection of multiple neural and humoral systems. LHA GABAergic neurons
in particular have emerged as potent actuators of arousal, goal-directed behavior as well as both negative and
positive valence behavior. Within this broad class of inhibitory LHA neurons lie poorly resolved but functionally
important subpopulations, which may differentially determine behavioral output. Important among these is a
population of putative inhibitory neurons that express the neuropeptide melanin-concentrating hormone (MCH).
LHA MCH-expressing neurons (LHAMCH) display remarkable functional diversity, sending extensive projections
throughout the brain and coordinating a broad range of physiological functions and behaviors, including the
modulation of sleep-wake states, feeding, motivated behavior, stress and memory. However, experimental
manipulations of LHAMCH neurons are largely interpreted in the context of LHAMCH neurons being a monolithic,
neuromodulatory projection system, creating a profound knowledge gap as to the source of their functional
diversity. There is, therefore, a critical need to delineate the unique cellular, circuit-level and behavioral impact
of LHAMCH diversity. In the previous grant cycle, we made significant progress towards our long-term goal of
defining the population structure of LHA GABAergic neurons, including the generation of the most
comprehensive cellular taxonomy to date of molecularly distinct LHA cell types in the mouse. Here, we will build
upon that progress through our investigation of: 1) two transcriptomically-distinct LHAMCH subpopulations that
differentially express the neurokinin 3 receptor (NK3R), the receptor for neurokinin B (NKB); 2) and a novel
projection from NKB neurons in the central extended amygdala to the LHA. In Aim 1, we will determine whether
distinct LHAMCH subpopulations give rise to functional sub-circuits that project to different targets in the brain and
release different neurochemicals using a precise intersectional viral strategy based on the enrichment of NK3R
in one LHAMCH subpopulation over the other. In Aim 2, we will explore whether differential engagement of LHAMCH
subpopulations elicits distinct behavioral repertoires using two parallel intersectional strategies for
optogenetically targeting LHAMCH subpopulations and then subjecting animals to a suite of behavioral
assessments. In Aim 3, we will investigate the biological mechanisms underlying NKB/NK3R signaling in the
central extended amygdala–LHA circuit through a detailed electrophysiological investigation of NKB/GABA co-
transmission onto LHAMCH neurons, and by studying the behavioral impact of these projections. Together, the
proposed experiments will address outstanding questions concerning the cellular and circuit-level functions of
LHAMCH neuron diversity, which is necessary both for a mechanistic understanding of LHA circuit function, and
as a critical precursor for identifying therapeutic targets for neuropsychiatric, sleep and metabolic disorders.

Public health relevance
PROJECT NARRATIVE The lateral hypothalamus (LHA) orchestrates fundamental behaviors such as arousal, stress and reward, and disruption of neural circuits in this region is associated with disorders of sleep, feeding and motivated behavior, which profoundly affect our physiological well-being and mental health. This proposal will use new and informative cellular and behavioral techniques to dissect the circuits and signaling pathways through which specific LHA neurons shape physiology and behavior. In so doing, we hope to identify targets for therapeutic intervention in treating and improving the quality of life of patients suffering from neuropsychiatric illnesses, addiction, post-traumatic stress disorder, sleep and metabolic disorders.